HIV-1 Intasome Assembly and Function

HIV-1 INTASOME ASSEMBLY AND FUNCTIONS
PROJECT SUMMARY / ABSTRACT
New HIV-1 retrovirus infections continue to drive a worldwide pandemic. Combined drug therapies have helped
to blunt the clinical outcomes that afflict HIV-1 infected individuals. However, drug-resistance virus mutations
that challenge these treatment regimens persist, making identification of new drug targets of crucial importance.
HIV-1 integration into the human genome is essential for a productive infection. Integration is catalyzed by the
retrovirus encoded integrase (IN), which forms a multimeric complex with the long terminal repeat (LTR) ends of
the reverse-transcribed viral cDNA (termed an intasome and/or pre-integration complex). Structural
comparisons show that all seven retrovirus genera maintain a conserved intasome core (CIC) configuration,
which precisely positions the LTR-ends for catalytic strand-transfer into a genomic target site during integration.
Different retrovirus family members expand the size of the CIC by appending additional IN subunits. For
example, the prototype foamy virus (PFV) intasome assembles as a simple tetramer while the mouse mammary
tumor virus (MMTV) forms an octamer by attaching IN dimers to either side of the CIC. IN octamer, decamer,
dodecamer (12-mer) and hexadecamer (16-mer) intasomes have been reported for HIV-1. The contributions of
IN-multimer architecture to HIV-1 biology and biophysical chemistry is unknown.
The assembly processes that ultimately result in an HIV-1 intasome remain enigmatic. Accumulating evidence
suggests that the viral capsid containing the HIV-1 genome is imported into the nucleus where assembly of the
intasome occurs in concert with capsid disassembly. Integration into the genomic chromatin then occurs 1-2 µm
from the capsid disassembly site. HIV-1 integration is facilitated by host factors that include LEDGF/p75. We
and others have found that LEDGF/p75 is required for efficient HIV-1 intasome assembly in vitro. These
observations underpin several key unanswered questions: What are the progressions that result in an
assembled HIV-1 intasome? What is the role of LEDGF/p75 in intasome assembly? What is the impact of IN-
multimer architecture on intasome stability and genomic target site selection in vitro and in vivo?
We propose to utilize innovative real-time single molecule imaging and analysis to understand the contributions
of IN-multimer architecture on HIV-1 mechanics with the following Specific Aims: 1.) determine the IN-subunit
assembly progressions that control multimeric HIV-1 intasome architecture, 2.) determine the role of HIV-1
intasome architecture on the dynamic interactions with defined chromatin target DNA in vitro, and 3.) determine
the role of HIV-1 intasome architecture on targeting host chromatin features in cellulo.
These studies are designed to interrogate the animated processes that support HIV-1 intasome architecture
with the goal of identifying additional retroviral progressions that may be exploited as therapeutic targets.

Public health relevance
PROJECT NARRATIVE Retroviruses must integrate into their host genome to cause a variety of devastating diseases including AIDS (HIV-1) and leukemia (HTLV-1). Integration into the host genome is catalyzed by a complex of the viral integrase (IN) protein with the viral DNA (termed an intasome), that for some retroviruses forms simple IN tetramers (HTLV- 1) and for others larger IN-multimers (8-16-mers for HIV-1). The goal of this proposal is to utilize advanced single molecule imaging technologies to quantitatively examine HIV-1 intasome assembly, stability, target DNA capture and integration mechanics.